Postnatal functional biomarkers of hippocampal integrity in adulthood and aging

DESCRIPTION (provided by applicant): Mounting evidence indicates that adult mental health status is strongly influenced by the quality of early life care. Abuse, neglect, isolation, and poverty have all been associated with poorer cognitive abilities in adulthood and aging. Moreover, the proportion of the US population that is elderly currently grows at a rapid pace and will reach 20% of the total population by 2030. This translates into a troubling burden on the US health care system to treat aging-related cognitive decline. However, this problem may be avoided if rapid action is taken to identify at-risk individuals and create prophylactic interventions. A better understanding of individual risk for memory impairment in adulthood and aging can be gained by knowing how neural systems that regulate memory are assembled during postnatal development. The proposed project is geared toward understanding the episodic and prospective memory impairments that are associated with human aging by focusing on the postnatal age in rats when these memory systems are undergoing their final maturation, the end of the third postnatal week. This age in rats parallels the final maturation of episodic memory in humans, which begins at about three years after birth. This lifespan-based research design employ assays at the molecular, cellular, pharmacological, systems, and behavioral levels. More specifically, the proposed experiments examine changes in the molecular structure of fast-acting synaptic glutamate receptors (AMPA receptors) at hippocampal synapses and relationships to alterations in neuronal function and spatial navigation ability. This multidisciplinary project should uncover early biomarkers for impending memory impairment, which will aid in understanding the considerable variability in episodic and prospective memory abilities in adulthood and aging. Additionally, findings will improve the design of prophylactic measures for memory maintenance and promote more effective treatments for memory impairments in aging.

Public health relevance
PUBLIC HEALTH RELEVANCE: The elderly population in the US continues to grow at a staggering rate meaning there are more and more individuals suffering cognitive impairment. As such, for individual, social, and economic reasons, it is critical to understand how memory systems are built and what makes them susceptible to decline in aging. Our research promotes the discovery of earlier markers of impending memory loss and the development of effective interventions.